Continuing to Support and Enhance an Integrated Food Safety System Through Implementation of Program Standards, Training, Data Sharing, and Collaboration

AFDO 2021 Alliance to Support Integrated Public Health System
Activities Application: Project Summary
The Association of Food and Drug Officials (AFDO) will direct and implement the activities under
this cooperative agreement which will facilitate FDA’s implementation of the Food Safety
Modernization Act (FSMA) and help increase mutual reliance between agencies, improve public
health protection, and help develop a nationally Integrated Food Safety System (IFSS).
AFDO has been representing regulatory food programs, including state manufactured food
programs, since 1896. The Principal Investigator and project staff include former state
manufactured food program managers that have extensive experience developing state food
safety programs, implementing programmatic change to achieve conformance with the
requirements of the MFRPS, and collaborating with FDA on manufactured food related issues
and IFSS activities.
Major activities conducted under this cooperative agreement include but are not limited to:
 Providing oversight and support to the Manufactured Food Regulatory Program Alliance
(MFRPA) to support state continuous improvement in the implementation of the
Manufactured Food Regulatory Program Standards (MFRPS);
 Conducting research and surveys on the capabilities of state manufactured food
programs;
 Researching and developing mechanisms to enhance data sharing;
 Maintaining and enhancing the secure online MFRPA Portal for sharing information and
data related to best practices, guidance documents, procedures, and other critical tools;
 Maintaining and enhancing directories for subject matter experts and the Directory of State
and Local Officials (DSLO) to improve interagency communication and provide access to
key contacts necessary for inter-agency collaboration in an IFSS;
 Collaborating to develop, deliver, and support state attendance at food safety and defense
training programs that enhance conformance with the MFRPS and implementation of
FSMA. Training will include the face-to-face annual meetings for the MFRPA and Rapid
Response Teams (RRT), as well as web-based and face-to-face training courses
designed to increase core regulatory and scientific knowledge;
 Researching methods to further promote food safety related regulatory careers with
colleges and universities and developing opportunities for experiential learning for college
students and food safety professionals in manufactured food topics.

Public health relevance
AFDO 2021 Alliance to Support Integrated Public Health System Activities Application: Project Narrative The Association of Food and Drug Officials’ (AFDO) efforts under this cooperative agreement are intended to facilitate long-term improvements to the national food safety system by strengthening federal – state collaborations and improving state’s regulatory surveillance and protection programs for manufactured foods. AFDO will support and contribute to the Manufactured Food Regulatory Program Alliance (MFRPA) as they work with states to develop best practices, develop and support training initiatives, and assist state programs in achieving programmatic improvement and conformance with the Manufactured Food Regulatory Program Standards (MFRPS). Through effective interagency collaboration, development of critical communication and data sharing strategies, and state manufactured food programmatic improvements, this project will help achieve a nationally Integrated Food Safety System (IFSS) and assist the U.S. Food and Drug Administration (FDA) in achieving their mandates under the Food Safety Modernization Act (FSMA). 1 of 1